Defining the changing microbiome composition and host-microbe mechanistic effects following Apc inactivation during colorectal cancer pathogenesis

Project Summary
Globally, colorectal cancer (CRC) is the second leading cause of cancer-related deaths in men and women
and is projected to increase by 70% in the next 20 years. One of the earliest initiating events of CRC is
mutation of adenomatous polyposis coli (APC), a tumor suppressor gene. This mutation initiates the gradual
progression from normal proliferating colon epithelial cells (CECs) to dysplastic lesions, to the eventual
formation of tumors, known as adenomas. Somatic APC mutations occur in >80% of sporadic CRCs. Growing
evidence demonstrates that factors within the local microenvironment can significantly influence cancer risk
and onset. One key characteristic of the colon adenomatous environment is an imbalanced microbiome.
Disruption in the makeup of these microbiota, known as dysbiosis, is related to many diseases, including
colitis, inflammatory bowel disease, and CRC. While dysbiosis contributes to promoting adenoma progression
and CRC, whether APC mutation triggers changes in the local microenvironment to facilitate tumor progression
and microbiome dysbiosis remains largely unknown. Using an inducible murine model of CEC Apc truncation,
our lab found that Apc inactivation and subsequent colon tumorigenesis results in microbiome dysbiosis and
outgrowth of pathogenic species, further, associated with increased bacterial mucosal adherence. This
proposal aims to define the timing and mechanisms by which the early microbiome changes following Apc
inactivation. We hypothesize that Apc loss alters the microenvironment to cause early loss of commensal
species and provides a habitat for pathogenic outgrowth and pro-carcinogenesis. We will test our hypothesis
through the following aims. Aim 1: Defining the effects of Apc inactivation on the composition, spatial/temporal
dynamics, and tumorigenic potential of the host microbiome. Using 16S rRNA amplicon sequencing and
microbiology, I will identify early microbiome changes following Apc loss during gradual colon tumorigenesis
and will determine if this differs by colon region. I will use germ-free models to evaluate if the changing
microbiome is sufficient to induce colon tumorigenesis. Aim 2: Identifying the mechanism(s) by which Apc
inactivation contributes to microbiome dysbiosis and the expansion of pathogenic species. I will utilize
transcriptomics and metabolomics to examine changes in metabolic pathways and gene regulation in
association with changes in microbiome composition and timing of Apc inactivation. This research will provide
novel insights into the events occurring upon Apc mutation and the crosstalk between mutated CECs and the
local microbiome.

Public health relevance
Project Narrative Colorectal cancer (CRC) is the second leading cause of cancer mortality globally and understanding the microbiota contributions to disease development is predicted to lead to new approaches to CRC prevention and therapy. In this proposal, using a murine model, I will define how genetic loss of adenomatous polyposis coli (Apc), a CRC driver mutation present in at least 80% of CRC, modulates the microbiome throughout the time course of colorectal tumor development. I expect my results to provide support in the future for innovation in CRC patient care.